Graduate Research Training in Perinatal Biology

DESCRIPTION (provided by applicant): This is an application for renewal of the institutional training grant, graduate research training in perinatal biology. The goal, of this interdisciplinary post-doctoral program of the Cardiovascular Research Institute and Departments of Pediatrics and of Obstetrics, Gynecology and Reproductive Science at the University of California San Francisco, is to provide comprehensive training in perinatal science and mentored career development for pediatricians and obstetricians with MD or MD, PhD degrees and who are committed to an academic career with a strong research component. The program provides advanced research training for clinicians in basic laboratory science, clinical investigation or studies in epidemiology, health services or health policy related to maternal, fetal and neonatal illnesses. The key elements of the proposed training are: (1) a mentored research experience, (2) scientific course work, (3) career development workshops, (4) interdisciplinary experiences and (5) continuing review and evaluation. The program is designed to provide 2 to 3 years of advanced research training. A large number of exceptionally well qualified faculty have committed their support as research mentors for this program. All fellows will take courses in Responsible Conduct in Research, Scientific Writing and the Art of Lecturing. Additional course work in the specific field of research will be planned by the fellow and research mentor. Each fellow will be supported by a three member mentoring committee, who will meet regularly (and no less than twice a year) with the fellow to assist in setting and monitoring progress towards research and career goals. Evaluation of the overall program is by a UCSF Advisory Committee and an External Review Board of prominent researchers and mentors. The proposed program is designed to strengthen this program that has an excellent record for 24 years of graduates becoming productive researchers and academic leaders in their respective fields of Maternal-Fetal Medicine and Neonatal-Perinatal Medicine.